Cancer Center Administration

SUMMARY/ABSTRACT: ADMINISTRATION
The Office of Translational Research (OTR), under the leadership of CCSG deputy director Dr. Robert Bast,
coordinates and implements all administrative functions related to the CCSG. Dr. Bast has a dual reporting
relationship, reporting directly to Dr. Giulio Draetta, chief scientific officer, and to Dr. Peter Pisters, MD
Anderson president and CCSG PI for matters relating to the CCSG. Dr. Bast's staff provides administrative
support and financial, scientific, and technical oversight for the CCSG programs; for all institutional shared
resources, including CCSG core facilities; and for all other CCSG components, including Clinical Protocol and
Data Management (CPDM), the Protocol Review and Monitoring System (PRMS), Community Outreach and
Engagement, Career Enhancement and Related Activities, Development Funds, Senior Leadership, Planning
and Evaluation, and CCSG administrative supplements. OTR staff serve on many of MD Anderson's advisory
and oversight committees, including MD Anderson's Moon Shot Operations and Executive Committee and
committees responsible for capital equipment allocation, oversight of research data storage, and financial
controls. Administrative support is provided in the following areas: 1) business operations and financial
management of shared resources; 2) central organization and coordination for the scientific and technical
aspects of shared resource operations; 3) facilitation of programmatic interactions and engagement; 4)
facilitation of communication between center director, program leaders, shared resource directors, and
program members; 5) development, management, and maintenance of databases for program funding,
program membership, program member publications, program member biographical information, and shared
resource utilization; 6) allocation and monitoring of the use of CCSG development funds; 7) coordination and
writing of CCSG progress reports and competitive renewal applications; and 8) organization of CCSG
Executive Committee and annual External Advisory Board meetings.